Functions for novel IL-15-responsive macrophages in the uterus during pregnancy

PROJECT SUMMARY
The goal of my five-year Mentored Clinical Scientist Research Career Development Award is for me to develop
into a productive, independent academic investigator in the field of reproductive immunology. I completed an MD
and a PhD in the field of cellular immunology, and I now seek to apply my interest in dysregulated immunity to
the public health threat of adverse fetal and maternal outcomes of pregnancy. I am now a physician-scientist in
Neonatology and Assistant Professor on faculty at Children’s Hospital of Philadelphia (CHOP) and the University
of Pennsylvania (Penn). My primary mentor for this award, Dr. Edward M. Behrens, is a physician-scientist and
Chief of the Division of Rheumatology with a longstanding track record of scientific innovation and providing
exceptional mentoring to trainees at all levels. As an internationally-recognized expert in innate immunity and
inflammatory disorders, Dr. Behrens’s work complements my own. We are thus poised for productivity. My
scientific advisory committee includes scientists and physician-scientists with collective expertise in all aspects
of the proposed work, from placental biology to next-generation sequencing. I am also extremely fortunate to
have the unreserved support of CHOP and Penn, whose combined resources are unmatched.
The goal of this one-year supplement is to provide funding for additional personnel who will promote my to return
to full research productivity after facing a critical life event soon after opening my laboratory. Given the extent of
my caregiving responsibilities for my two young children during this period, I have already received an extension
of the tenure clock from my supportive institution. This supplemental research support from the NIH will be
instrumental in timely completion of the original aims of my K08. Scientifically, the proposal focuses on roles for
novel macrophages that I discovered under the guidance of Dr. Behrens, called CD122+Macs, in normal and
threatened pregnancy. Enriched in the uterus in mice and humans, CD122+Macs express high levels of CD122,
the hallmark of responsiveness to interleukin-15 (IL-15). These novel Macs signal and function when exposed
to IL-15, surprising because killer lymphocytes like natural killer (NK) cells, not Macs, are the classical targets of
IL-15. Disrupted homeostasis of IL-15 is associated with numerous adverse outcomes of pregnancy, including
preeclampsia and abnormal feto-placental growth but through unknown mechanisms. Based on prior literature
and my preliminary data, my central hypothesis is: IL- 15 exerts its influence over outcomes of pregnancy not
only by maintaining NK cells but also by modulating the inflammatory properties of novel CD122+Macs. The
aims of this proposal will establish: 1) Mechanisms by which CD122+Macs respond biochemically and
transcriptionally to IL-15 and 2) IL-15-dependent requirements for CD122+Macs in pregnancy in vivo. This
proposal will close major gaps in knowledge regarding the mechanism by which IL-15 acts on a novel cellular
target to ensure maternal and fetal health during pregnancy.

Public health relevance
PROJECT NARRATIVE Number and quality of immune cells in the uterus drive development of the fetal placenta, which is responsible for nourishing the fetus during pregnancy. Major complications of pregnancy impacting both mother and fetus result when immune cells in the uterus function abnormally. This project will provide critical knowledge regarding the function of a subset of uterine immune cells, called macrophages, promote fetal growth and development.